Clinical Studies Core

CORE B, CLINICAL CORE SUMMARY
The success of the entire program is contingent upon successful accrual of human samples. The purpose of
Core B (Clinical Core) is to provide a centralized resource for the accrual of human lymph node (LN), head and
neck, nasopharyngeal swab (NP), peripheral blood mononuclear cells (PBMC), and sera and/or plasma samples.
This Core will also ensure the quality and uniformity of handling samples received. In addition to recruitment
goals, the goal of this Core is to design, establish, and maintain IRB approval while overseeing the quality control
of coded clinical information and donor samples. These functions are crucial to provide a strong foundation for
the studies described in the three proposed projects. The Core will be based at LJI at the John and Susan Major
Center for Clinical Investigation, the CCHI’s home institution. The Clinical Core will work closely with subcontracts
(Liverpool, U.K. and UCSD) to enable the acquisition of additional samples for Projects 1 and 3.